Precision MRI of Left Atrial Fibrosis for Patients with Atrial Fibrillation

Project Summary/Abstract: Catheter ablation targeting the pulmonary veins and other atrial sites has emerged
as the best intervention for restoring and maintaining sinus rhythm; however, 1-year success rates are only 60-
70%. Because ablation does not benefit all atrial fibrillation (AF) patients, a personalized medicine approach is
needed to avoid an unnecessary procedure (cost >$20,000, risk ~5%) for expected non-responders (30-40%).
Potential predictors of AF recurrence derived from standard clinical and imaging metrics have proven to be of
limited use. Left atrial (LA) fibrosis is more promising, because fibrosis plays a central role in the development
of an arrhythmogenic substrate for AF and may be a marker for more extensive disease less amenable to
standard pulmonary vein isolation. In fact, LA fibrosis assessed with 3D LA late gadolinium enhancement (LGE)
cardiovascular magnetic resonance (CMR), pioneered by the Utah group, has shown promise for predicting AF
recurrence post-ablation. However, the “Utah” classification of LA fibrosis has garnered skepticism because of
a lack of independent verification and validation. This lack of reproducibility stems from two fundamental
methodologic deficiencies: (a) inadequate spatial resolution (1.5 mm x 1.5 mm x 2.5 to 5 mm) and contrast-to-
noise ratio (CNR) and lengthy scan time (~11 min) at 1.5 Tesla and (b) unreliable image analysis techniques for
quantification of fibrosis in the thin (~2 mm) LA wall. These deficiencies preclude widespread adoption of LA
fibrosis quantification in clinical practice.
To push the field of forward through these obstacles, we propose to develop disruptive technologies for
quantification of LA fibrosis by integrating the following advanced techniques: (1) free-breathing 3D LGE CMR
balanced steady state free precession (b-SSFP) readout with stack-of-stars k-space sampling and compressed
sensing (CS) or eXtra-Dimensional Golden-angle RAdial Sparse Parallel (XD-GRASP) reconstruction with self-
gating respiratory motion for achieving unprecedented image quality (i.e. CNR) with high spatial resolution (1.3
mm x 1.3 mm x 1.5 mm) and acceptable scan time (6 min) at 1.5 Tesla and (2) novel signatures technique for
precise quantification of LA fibrosis using stochastic analysis. Unique advantages of the proposed signatures
technique over standard analysis techniques include: (2a) more precise threshold-free fibrosis definition, (2b)
insensitivity to LA segmentation, (2c) self-correction for intensity inhomogeneity, (2d) standardization and
patient-specific quantification, and (2e) full automation and fast (2 min) processing.
The specific objectives of this multi-center study are to: a) develop and validate robust 3D LA LGE CMR
acquisition and reconstruction methods for 1.5 Tesla, (b) develop and validate a novel LGE signatures technique
for quantification of LA fibrosis, and c) evaluate the prediction accuracy and reproducibility of LA fibrosis
signatures across two sites. This proposal has high potential impact because it addresses two fundamental
methodologic deficiencies precluding widespread adoption of LA fibrosis quantification in clinical practice.

Public health relevance
PROJECT NARRATIVE: The goal of this proposal is to develop and validate a new magnetic resonance imaging (MRI) approach for measuring the severity of fibrosis in the left side of a heart chamber called atrium, for the purpose of predicting whether patients will revert to atrial fibrillation following initial successful intervention. Unfortunately, standard MRI and analysis methods have two fundamental deficiencies (inadequate spatial resolution, unreliability) that hinder accurate reading of fibrosis. Our new approach integrating advanced engineering and MRI physics techniques successfully addresses the deficiencies associated with standard methods and enables doctors to correctly predict recurrent atrial fibrillation following intervention.